Uncovering the Role of Histone Acetylation in Tetrabromobisphenol A-induced Developmental Toxicity during Zygotic Genome Activation

Flame retardants (FRs) are a ubiquitous group of chemicals used in furniture, car seats, and children's products
and can leach into indoor dust, resulting in chronic exposures. Epidemiological and experimental evidence shows
that developmental FR exposures result in short- and long-term adverse health outcomes, but the knowledge
gap remains- what targets do they attack and how do they drive adverse outcomes? Using zebrafish, our
preliminary data on a brominated FR, tetrabromobisphenol A (TBBPA) shows that TBBPA exposures during
early developmental windows (cleavage, blastula, early gastrula) results in developmental delays, mortality and
downstream defects in dorsoventral patterning. These early windows are marked by a rapid maternal to zygotic
transition (MZT) and zygotic genome activation (ZGA) when maternally loaded mRNA degrade, and zygotic
genome is activated. Our mRNA-sequencing data reveals that TBBPA inhibits ZGA and targets chromatin
remodeling. Since the latter process is regulated by histone acetylation H3K27ac and catalyzed by P300 protein,
we used a P300 activator CfPB and showed that co-exposures with TBBPA and P300 activator mitigated the
TBBPA-induced phenotypes. Molecular docking showed strong binding affinities between TBBPA and P300.
Based on these, our overarching goal is to understand the diversity ofTBBPA-induced epigenetic and genetic
modifications and how they modulate embryonic development. Our oldective is to determine how TBBPA
disrupts ZGA through histone modifiers and the downstream consequences on chromatin remodeling and gene
expression. The central hypothesis is that TBBPA inhibits P300 activity and limits zygotic transcription by
inhibiting H3K27 acetylation and chromatin remodeling of zygotic genome. This hypothesis will be tested
through two specific aims. Within aim 1, we will conduct P300 activity assays and quantify of global and genelevel
H3K27ac using Western Blots and ChIP-seq. In aim 2, we will use ATAC-seq and nascent RNA-seq to
examine chromatin accessibility and nascent RNA transcription. We will also integrate the multiome data from
both aims into a gene regulatory model for systems level analyses of pathways that are impacted by TBBPA
during ZGA. Based on the sequencing outcomes, we will select specific targets and use qPCR to quantify gene
expression across environmentally relevant TBBPA concentrations. The grant is innovative, since it is the first
work to systemically assess how an environmental toxicant impacts ZGA through histone modifications and
leverages state of the art technologies, including nascent RNA seq, to describe a novel adverse outcome pathway
(AOP) for TBBPA early life exposures that spans multiple biological levels from epigenetic regulation
(acetylation), chromatin biology, co-regulated genes, signaling networks and organism development. The work
is significant since it will reveal how TBBPA directly or indirectly targets proteins or gene products and their
regulatory regions that modify onset of zygotic transcription and can be further used in mechanistic or
epidemiological studies to evaluate disease mechanisms.
Project Summary/Abstract

Public health relevance
The proposed research investigates the mechanisms of developmental toxicity of TBBPA- a high production volume flame retardant- and how it interferes with histone modification that are operant during zygotic genome activation. Through multiome assessments of genome-wide acetylation marks, chromatin accessibility and nascent transcription, we will uncover how TBBPA inhibits zygotic genome activation that results in developmental defects. The practical impact of this work is to gain a better understanding of gene products and their regulatory regions that modify zygotic transcription and can be further used in mechanistic or epidemiological studies to evaluate adverse developmental outcomes and disease mechanisms. Project Narrative